Expanding Minnesotas (MDA) Manufactured Food Program Efforts towards a Nationally Integrated Food Safety System and MFRPS Maintenance

Project Abstract
The intended outcome of this cooperative agreement is to advance efforts for a nationally
integrated food safety system (IFSS) by supporting the Manufactured Food Regulatory Program
Standards (MFRPS) and Food Protection Task Force (FPTF) Programs, facilitating the
development of state dietary supplement inspection program as well as supporting Special
Projects.
The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD)
licenses and inspects approximately 10,000 food facilities including 2,000 manufactured food
facilities in Minnesota. The MDA-FFSD has a dedicated Manufactured Food Program
responsible for manufactured food licensing, compliance, and inspection activities. The
Manufactured Food Program has 19 staff members including one program manager, two food
supervisors, one dedicated support person, and 15 field inspectors. FFSD has an additional 20
staff that fully or partially support the Manufactured Food Program in administrative capacities.
The MDA-FFSD, as part of this application, will create a strategic improvement plan that
outlines maintaining full conformance with the MFRPS through maintenance and continuous
improvement. MDA-FFSD will maintain a FPTF that provides a forum for all stakeholders of the
state food protection system and maximize the protection of public health through integration
activities. In addition, MDA-FFSD will initiate the development of a dietary supplement
inspection program and complete special projects that support FDA’s mission and vision for
building mutual reliance in an IFSS.

Public health relevance
Project Narrative The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD) seeks to maintain full conformance with the Manufactured Food Regulatory Program Standards (MFRPS) and promote continuos improvement of the standards along with maintaining a Minnesota Food Protection Task Force (FPTF) that provides a forum for all stakeholders of the state food protection system and maximize the protection of public health through integration activities. The MDA-FFSD will initiate a dietary supplement inspection program and complete special projects that support the Food and Drug Administration’s (FDA) mission and vision for building mutual reliance in an Integrated Food Safety System.